Deciphering Mechanisms for Triglyceride and Cholesterol Transport

Project 1: Deciphering Mechanisms for Triglyceride and Cholesterol Transport
SUMMARY/ABSTRACT
Project 1 investigators have devoted their careers to exploring basic mechanisms of lipoprotein metabolism in
health and disease. They discovered that an endothelial cell protein, GPIHBP1, is responsible for transporting
lipoprotein lipase (LPL) to the capillary lumen; that the LPL–GPIHBP1 complex is crucial for the margination of
triglyceride-rich lipoproteins (TRLs) along capillaries; and that GPIHBP1 protects LPL from spontaneous and
ANGPTL4-catalyzed unfolding/inactivation. Their efforts have resulted in >60 publications, many reflecting a
commitment to understanding human disease. For example, they identified GPIHBP1 mutations causing
chylomicronemia and uncovered a new human disease—chylomicronemia from GPIHBP1 autoantibodies.
Recently, Project 1 investigators and coworkers determined the structure of the LPL–GPIHBP1 complex. During
the next 5 years, Project 1 investigators will pursue two independent objectives. The first is to pursue ongoing
studies of intravascular lipolysis, building on insights from the structure of the GPIHBP1–LPL complex. That
structure, along with new reagents, new methodologies, and expert collaborators, have made intravascular
lipolysis more exciting than ever. Key goals include defining amino acid residues required for GPIHBP1–LPL
interactions, exploring mechanisms underlying specific “chylomicronemia mutations,” understanding a gain-of-
function polymorphism in LPL, defining the role of GPIHBP1’s acidic domain in stabilizing LPL from
unfolding/inactivation, examining the function of GPIHBP1’s acidic domain in recruiting LPL from heparan sulfate
proteoglycan binding sites in the subendothelial spaces, and investigating how ANGPTL4 initiates the unfolding
and inactivation of LPL. We will also determine the structure of GPIHBP1 and LPL in association with an Fab
fragment of the LPL–specific monoclonal antibody 5D2. Our second objective is to investigate the distribution of
cholesterol in macrophages and the mechanisms by which macrophages dispose of cholesterol. In preliminary
studies, Project 1 investigators found that macrophages release, by plasma membrane budding, numerous 30–
70-nm particles. By NanoSIMS imaging, these particles are highly enriched in cholesterol, including the
metabolically active “accessible cholesterol” detectable by bacterial cytolysins (e.g., ALO-D4). The finding that
cholesterol-rich particles “bud” from macrophages raises many questions. What is the function of particle
budding? What is the composition of these particles? Is particle budding regulated? In collaboration with projects
2 and 3, project 1 will investigate the numbers and composition of macrophage particles in different settings
(e.g., sterol starvation, cholesterol loading, LXR agonist treatment, and deficiencies of LXRs, ABCA1, or
ABCG1). Preliminary NanoSIMS imaging studies showed that high-density lipoproteins are effective in unloading
cholesterol from macrophage-derived particles, implying that macrophage particle budding could be relevant to
reverse cholesterol transport and the emergence of cholesterol-laden cells in atherosclerotic plaques.